Human specific STING agonists for the treatment of cancer

PROJECT SUMMARY
Cellular innate immune sensors, such as STING (STIMULATOR OF INTERFERON GENES), have evolved to
detect microbial infection of the cell (1-3). STING controls the potent cytosolic DNA-stimulated innate immune
pathways and is activated by cyclic dinucleotides (CDNs) such as cyclic di-GMP and cyclic-di-AMP secreted by
intracellular bacteria following infection. Alternatively, STING can be activated by cyclic GMP-AMP (cGAMP)
generated by a cellular cGAMP synthase cGAS (MB21D1) after association with aberrant cytosolic dsDNA
species, which can include microbial DNA or self-DNA leaked from the nucleus (4). Association with CDNs
enables STING to activate the production of type I interferon (IFN) and pro-inflammatory cytokines, which
facilitate adaptive immunity (3). Aside from being critical for the protection against microbial infection, STING
signaling has been shown to be essential for facilitating robust anti-tumor immunity. Regulation of the
immune system to stimulate anti-tumor cytotoxic T cell responses is proving to be a powerful approach for the
effective treatment of a variety of cancers. For example, STING agonists, based on synthetic CDNs, have been
shown to exert potent anti-tumor properties likely by stimulating APCs and are now being evaluated in Phase I
trials for the treatment of cancer. However, such CDNs are highly labile and do not exert potent activity when
given systemically. This has limited their use/evaluation to intratumoral and oral administration. Here, we
describe a new generation of novel small STING agonists that activate STING signaling, that appear superior to
existing CDN’s, for evaluation in anti-tumor therapeutic strategies. The compounds have been generated by
STINGINN LLC, based in Miami, in collaboration with the University of Miami School of Medicine, FL.

Public health relevance
PROJECT NARRATIVE Stimulation of the immune system has been shown to be a powerful approach for the treatment of cancer. We have found that stimulation of an immune pathway controlled by a cellular molecule referred to as STING can effectively trigger anti-tumor responses. Here, we have generated a new array of STING-dependent compounds that we intend to evaluate as anti-cancer drugs.